Healthcare utilization and outcomes across the cancer care continuum: Understanding the impact of social risk factors and screening among Latino patients

PROJECT SUMMARY/ABSTRACT
In the United States (US), nearly half of patients with a history of cancer report experiencing social risks
including financial hardship, food insecurity, unstable housing, and transportation difficulties. Social risks may
have negative impacts on healthcare use and outcomes, such as delayed or forgone medical care, poor quality
of life and increased mortality. However, research on the associations between social risks and healthcare use
across the cancer care continuum is limited. Latinos experience more social risks, have lower use of many
cancer services, and suffer worse cancer outcomes across numerous cancer types than non-Latino Whites.
The lack of data on social risks among Latinos suggests that the extent and magnitude of the burden of unmet
social risks are not well defined, nor is the association between social risks and cancer health and healthcare
outcomes. To fill this gap, we propose a longitudinal, multi-level study of the associations between social risk
screening, social risk, and cancer outcomes using data from a community health center (CHC) network (where
Latino patients disproportionately receive care in the US) across more than 40 states and including over 2
million Latino patients. This robust and unique electronic health record (EHR)-based dataset will include
clinical, utilization, multi-level social determinants of health, tumor registry, and death data. Specifically, we aim
to (1) define the use, and variation, of social risk screening in Latinos (overall and by place of birth) compared
to non-Latino Whites; (2) determine the prevalence and type of social risks, and the associations with the
receipt of recommended cancer preventive screening services, compared to non-Latino Whites; and (3) using
novel CHC network data linked to cancer registry data from Oregon, Washington, and California, determine
whether social risk screening, and the social risks identified, are associated with stage at cancer diagnosis,
treatment initiation, and cancer mortality, comparing Latinos (overall and by place of birth) to non-Latino White
patients. Findings will be disseminated across multiple patient and provider networks, and help inform patients,
community practices, providers, and policy makers about the extent to which social risks serve as barriers to
receipt of quality cancer care in Latinos, as well as the importance of integrating social risk screening within the
healthcare setting to improve cancer outcomes.

Public health relevance
PROJECT NARRATIVE This project will study the relationship between social risks, such as transportation difficulties and housing challenges, and social risk screening with cancer outcomes among Latino patients who receive care at community health clinics across the United States. The results of this project will help us better understand the impact of social risks on cancer-related care (e.g., cancer prevention screening) and cancer-related outcomes (e.g., stage of cancer at diagnosis). This study will also help guide future efforts to screen for social risks in community healthcare settings, to help ensure that patients can get the cancer care they need to improve their health outcomes.